Microbubble Cavitation for Improving Hepatocellular Carcinoma Radioembolization

The use of radioembolization has been shown to be successful for the treatment and downstaging of
hepatocellular carcinoma (HCC) as well as liver metastases, and advantages over traditional chemoembolizaion
have been reported. The local beta emissions from this technique have been shown to provide therapeutic effect
within the tumor. Dosages range from 110-150 Gy, but radiation delivered to malignant tissue is dependent on
distance from the yttrium source. Radiotherapy is only effective in treating HCC in doses above 50 Gy.
Consequently, treatment response after radioembolization is between 25-60% when based on response criteria
in solid tumors (mRECIST). We propose to use ultrasound-triggered microbubble destruction (UTMD) to improve
radioembolization of HCC. This technique uses commercial ultrasound contrast agents, whose ultrasound
triggered cavitation results in a variety of well documented bioeffects. Localized microbubble cavitation has been
shown to sensitize malignant tissue to radiotherapy by inducing vascular endothelial-cell apoptosis. Thus,
localized UTMD after radioembolization of HCC may potentially improve tumor response by selectively
sensitizing malignant tissue to radiotherapy. In addition, the rate of contrast reperfusion after a destructive pulse
can be quantified and used to estimate blood perfusion and fractional vascularity. Changes in fractional
vascularity and perfusion may be a potential earlier indicator of treatment response, thereby enabling earlier
retreatment in non-responding patients.
We propose a clinical trial using localized microbubble cavitation followed by imaging of contrast washing
back into the tumor (termed reperfusion) to improve patient outcomes and predict treatment response earlier
than the current clinical standards. Patients scheduled for radioembolization of HCC will be randomized to
receive radioembolization alone or radioembolization in combination with a contrast ultrasound exam 2-4 hours
and 7 and 14 days post radioembolization. A flash destruction-replenishment technique will be used to induce
microbubble cavitation at multiple planes within the tumor vasculature. Tumoral response, safety, radioactive
bead distribution, liver function, and alpha fetal protein, will then be evaluated and compared between groups.
As a secondary aim, tumor perfusion will be quantified in the experimental group based on the rate of contrast
agent reperfusion following each destructive ultrasound pulse. Patients will then be stratified according to
mRECIST criteria 3-4 months post treatment based on their clinically scheduled follow-up MRI/CT study.
Microbubble-derived tumor reperfusion rate will be compared between groups to determine if treatment response
can be predicted 7-14 days post therapy. Once validated, this technique is expected to improve patient outcomes
by selectively sensitizing malignant tissue to radiotherapy, and by enabling alternative forms of treatment through
earlier identification of patients not responding to therapy.

Public health relevance
The use of radioembolization has been shown to be successful for the treatment and downstaging of hepatocellular carcinoma as well as liver metastases, with response rates of 25-60%. Localized microbubble cavitation triggered by noninvasive ultrasound has been shown to sensitize malignant tissue to radiotherapy by inducing vascular endothelial-cell apoptosis. We propose a first-in-humans randomized clinical trial to determine the benefits of using localized microbubble cavitation to improve patient outcomes and predict treatment response.